Motion and distortion-robust quantitative MRI of early brain developments

Motion and distortion-robust quantitative MRI of early brain developments
The objective of this research is to significantly enhance quantitative imaging technology for in-vivo analysis of
neurovascular structures and the early developing brain's response to perinatal stroke. Quantitative MRI
(qMRI) is becoming essential in neuroimaging, offering superior capabilities over qualitative MRI. Specifically,
quantitative susceptibility mapping (QSM) and R2* mapping provide early insights into developmental
abnormalities such as brain hemosiderin deposits, intracranial hemorrhage, and blood oxygenation levels.
However, quantitative perinatal MRI faces significant challenges: 1) fetal motion restricts imaging to 2D and
often introduces artifacts, and 2) geometric and field distortions are amplified by fetal and maternal organ
movements. Currently, our understanding of early brain development and common neurodevelopmental
abnormalities is primarily derived from postmortem (in-vitro) studies due to the lack of advanced quantitative
imaging technology. This project aims to bridge these gaps by developing an innovative, motion- and
distortion-robust quantitative MRI technique. This involves creating and evaluating a novel approach based on
3D motion-robust radial multi-echo MRI combined with advanced image processing and reconstruction
techniques. These methods will correct for motion and reconstruct high-resolution quantitative data directly
from the data space, allowing detailed visualization of the neurovascular structure in small fetal and neonatal
brains. The project has three specific aims: 1) improving neonatal quantitative MRI for moving subjects, and 2)
achieving high-resolution susceptibility-weighted, quantitative susceptibility and R2* maps in the developing
brain despite subject movements 3) quantitative evaluations of the proposed approach against Echo planar
imaging-based approaches on healthy and patients with perinatal stroke. This research is significant because it
enables high-resolution in-vivo mapping of the neurovascular structure in the fetal brain despite motion,
simplifies MRI research for neonates and preterm infants with motion-robust acquisition and reconstruction
techniques that compensate for small head movements, reduces the need for sedation and anesthesia in
clinical MRI of neonates and uncooperative patients, corrects motion while increasing the spatial resolution of
quantitative MRI, thereby dramatically improving the analysis of neural structure and connectivity in early brain
development.

Public health relevance
Project Narrative: The proposed research is relevant to public health because it develops innovative quantitative medical imaging technology that enables fast, efficient, and safe in-vivo evaluation of neurovascular structures and characterization of normal versus abnormal brain growth in fetuses and neonates with perinatal stroke. The proposed research is relevant to the NIH mission as it pertains to developing fundamental technology and knowledge that enables the development of early preventive interventions that lengthen life and reduce the burdens of human disability.